Impact of prenatal alcohol and methadone exposure on dopamine regulation of BLA plasticity

Abstract
Substance use during pregnancy is a shockingly common occurrence in lieu of compelling evidence
demonstrating a multitude of neurodevelopmental deficits in offspring with prenatal substance exposure. While
the consequences of prenatal alcohol exposure (PAE), specifically, are the most understood, poly-drug use
during pregnancy, particularly alcohol and opioids, have become increasingly common, including opioids used
for maintenance therapy such as methadone. However, there is little to no understanding of the combined
effects of prenatal alcohol and opioid exposure on the developing brain. A recent study showed that newborns
and young children with combined prenatal alcohol and opioids have worst emotion regulation and processing
deficits relative to those with exposure to a single drug, effects that we and others have demonstrated in
preclinical models. Interestingly, plasticity within the basolateral amygdala (BLA) is associated with emotion
processing through modulation by the dopamine system. And, more importantly, the BLA and dopamine
systems are targets of prenatal alcohol and opioid, including methadone, exposure. Our preliminary data
suggest that males are more sensitive to PAE, while females are more sensitive to prenatal methadone
exposure (PME). Based on this, we hypothesize that combined PAE and PME leads to magnified social and
non-social anxiety through dysregulation of DA-modulation of synaptic plasticity within the BLA in a sex-
specific manner. To test our hypothesis, we will use our established models of PAE and PME. Aim 1 will
determine how PAE+PME alter social and non-social anxiety-like behaviors relative to exposure to only one
substance. Aim 2 will test how PAE+PME derails DA modulation of synaptic plasticity within the BLA. These
timely and innovative studies will test novel and unique hypotheses surrounding the long-term effects of a
surprisingly common pattern of prenatal exposures and identify a potential neural target as a foundation that
can be further interrogated in a future R01.

Public health relevance
Impact of Prenatal Alcohol and Methadone Exposure on Dopamine Regulation of BLA Plasticity While combined alcohol and opioid use during pregnancy is shockingly common, little to nothing is known about the consequences of this polydrug exposure on offspring. Prenatal exposure to either alcohol or opioids, including methadone as a maintenance therapy for opioid use disorder, leads to impairments in socioemotional processing. This innovative and timely proposal will examine how prenatal co-exposure to alcohol and methadone alter socioemotional behaviors and dopamine regulation of synaptic plasticity within the basolateral amygdala in adult offspring.